Early Detection and Treatment of Emerging Cognitive-Linguistic Impairment in Minority Cognitive Aging and Primary Progressive Aphasia

Project Summary / Abstract
Dementia is a daunting public health crisis facing many industrialized nations. A key component of the global
action plan for dementia proposed by the World Health Organization (WHO) involves early detection and the
development of novel therapeutics.1 There exist great racial and socioeconomic barriers to dementia care in the
United States. Many existing neuropsychological measures lack sensitivity to accurately screen for dementia in
under-represented minority populations. During the next project period, we will focus on early detection of
emerging semantic deficits in naturalistic language samples. Our focus is on changes in language cognition,
and physiology of the pupil response function among a cohort of older African American adults at elevated risk
for dementia. We will derive age-based norms for language content during narrative production and evoked
pupillary dynamics (e.g., speed of pupil dilation) during both the production and perception of language. Our
studies will elucidate the relationship between changes in executive functioning and semantic knowledge over
the span of five years in a radically underserved population.

Public health relevance
Project Narrative This project will advance our theoretical understanding of human semantic memory while providing a set of diagnostic and clinical tools for detecting age-related cognitive impairment in a longitudinal cohort of older African American adults at high risk for dementia. One of our major goals is to disseminate tools for detecting subtle changes in naturalistic language samples that portend the onset of Alzheimer's Disease or an associated disorder. In addition to characterizing language and language change, we will disseminate a database of pupillary functioning spanning tasks, light reflexes, and rest.